Coordination of chaperone interactions that dictate protein folding and trafficking

PROJECT SUMMARY
Proteins fold into their 3-dimensional shape with the help of chaperones and other protein folding factors,
which together comprise the proteostasis network (PN). During the protein quality control process,
transient binding interactions between individual client proteins and proteostasis factors mediate folding
into native functional structures, thereby ensuring trafficking to the correct cellular destination or facilitating
degradation of detrimental misfolded states. Consequently, imbalances in interactions between
proteostasis factors and client proteins result in quality control defects that lead to diverse protein
misfolding diseases, including highly prevalent neurodegenerative diseases such as Alzheimer’s and
Parkinson’s Disease, and loss-of-function diseases such as Cystic Fibrosis. The folding, maturation, and
trafficking of large multi-domain and multi-subunit proteins is a complex and highly client-specific process
that depends on engaging the appropriate component of the PN at the correct time. Many proteostasis
dependencies for individual client proteins are known, but little is understood about the engagement order
and whether correct sequential interactions are required for proper folding and trafficking. We have utilized
the power of chemical biology and quantitative proteomics to develop a new tool, time-resolved
interactome profiling, to interrogate the dynamics of the interaction between disease-associated protein
variants and the PN. We examined the coordination requirement of different proteostasis pathways as they
affect protein secretion (thyroglobulin) and loss-of-function protein misfolding (cystic fibrosis
transmembrance conductance regulator – CFTR). Loss of secretion of destabilized thyroglobulin variants,
a thyroid prohormone, is a leading cause of congenital hypothyroidism while misfolding and pre-mature
degradation of CFTR variants is the primary cause of Cystic Fibrosis. We have identified three projects
that leverage the utility of our approach and build upon the groundwork laid by our previous findings. These
include: 1) Determining the contribution of degradation factors to secretion loss of misfolded thyroglobulin
variants. 2) Elucidating the proteostasis dynamics of divergent multipass membrane proteins, and 3)
Enhancing the time-resolution of our time-resolved interactomics approach to capture early ER
translocation and folding dynamics. Results from our studies will provide significant new insights into how
the dynamics of protein folding and trafficking pathways can be manipulated therapeutically for disease
intervention.

Public health relevance
Proteins fold into their functional conformation and are transported to the appropriate subcellular location with the guidance of various protein folding and trafficking factors, which comprise the proteostasis network. This highly regulated process depends on correctly coordinating the necessary proteostasis factors, with imbalances leading to many different protein misfolding diseases. We are utilizing the power of mass spectrometry coupled with chemical biology tools to understand the coordination required for proper proteostasis network function to assess how such interactions may be dysregulated among disorders associated with abnormal protein folding.